Data Science Core for Biomedical Research

DATA SCIENCE CORE FOR BIOMEDICAL RESEARCH: SUMMARY
The Data Science (DS) Core serves as a centralized resource for providing expert and timely bioinformatics
and other DS-related consulting, analysis, collaborative research, management, and training solutions for a
broad range of high-throughput biomedical data. The DS Core will support the specific aims of HI-INBRE V by
providing a strong and integrated DS service in research, education, investigation, and creation of innovative
methodologies.
During INBRE IV, the Bioinformatics Core made substantial progress to serve as a solid foundation for
transition to the DS Core. We experienced an annual increase in the number of researchers utilizing the DS Core
services from almost all the HI-INBRE institutions. The DS Core has successfully provided
bioinformatics/biostatistics and other DS training and education opportunities to the HI-INBRE community.
During INBRE IV, the core infrastructure was also significantly enhanced and several Ph.D. level data scientists
were hired. The core has successfully contributed to peer-reviewed publications, grant applications and helped
investigators to obtain a variety of research awards.
In INBRE V, the DS Core will continue to function as an important component of the network. Specifically,
the DS Core will contribute to INBRE V objectives in three key ways: (i) Customized Services: the DS Core will
facilitate the acquisition of preliminary data for grant applications and subsequent research by HI-INBRE
investigators via consultation on experimental design and data management as well as offer expertise in data
analysis and interpretation; (ii) Education and Training: the DS Core will provide education in DS, as well as
support career development for student and emerging faculty researchers, with special attention given for
training DS skills to undergraduate students; (iii) Core Development: the DS Core will create tools and methods
or repurpose existing tools and strategies to accelerate advances in the sciences. In all of these activities, the
DS Core will work collaboratively with other local and national bioinformatics and DS cores. To reach these
goals, we propose three Specific Aims:
(1) Provide DS core services to support biomedical research needs of HI-INBRE investigators.
(2) Meet the upskilling needs of biomedical faculty whose research is becoming increasing computationally
intensive.
(3) Enhance the biomedical DS pipeline in Hawaii.
1